Network Lead Academic Participating Site Grant from the Roswell Park Cancer Institute

PROJECT SUMMARY
The Roswell Park Comprehensive Cancer Center (Roswell Park) has had a long tradition of
contributing to the national cooperative groups over many decades. Those contributions have
been scientific, administrative, and participatory (enrollment on clinical trials). Contributions have
been consistent and numerous over the years. This extension briefly summarizes the intent of its
4 PD/PI’s (Levine/Puzanov/Lele/Singh) and the membership of Roswell Park to sustain its
commitment to the many strengths inherent to cooperative group research: therapeutic advances;
a better understanding of the biology of cancer; cancer prevention; means to improve the quality
of life of cancer patients; piloting of new drugs and radiologic and radiation and surgical
techniques; establishing the relevance of new cellular and molecular advances to the predictive,
prognostic, and therapeutic approaches to patients; and the advancement of patient advocacy.
Investigators at Roswell Park and its supporting staff fully recognize the essential importance of
the timely and accurate submission of data and specimens to achieve these aims

Public health relevance
PROJECT NARRATIVE The aim of inter-institutional cooperative clinical research is to advance our understanding of cancer prevention, precancers, and both benign and malignant processes and, thereby, to improve our ability to treat people at risk or afflicted with them. These aims are accomplished by resolving scientific questions of importance regarding cancer biology and therapy through the cooperation of selected Institutions that can pool their intellectual, technical, and patient resources. The rapid accumulation of clinical data and experience through cooperative group research expedites progress in cancer therapy.